Mitochondria-derived dsRNA in brain aging and Alzheimer's disease

PROJECT SUMMARY
This F32 application is intended to support Dr. Rachel Doser’s postdoctoral research and training, and to
effectively prepare her for a career as an independent researcher. Dr. Doser is a new (<6 months) postdoctoral
research associate in Dr. Tom LaRocca’s Healthspan Biology Lab at Colorado State University. Under this
fellowship, Dr. Doser will investigate a novel contribution of mitochondria-derived double-stranded RNA
(mt-dsRNA) to neuroinflammation in aging and Alzheimer’s disease (AD). The rationale for the proposed
studies is that dsRNA is a potent activator of innate immune/inflammatory signaling, and mitochondria are a
major source of dsRNA, as bidirectional transcription of the circular mitochondrial genome results in the
formation of mt-dsRNAs. Although mt-dsRNA-induced immune activation has been shown to contribute to
certain cancers and autoimmunity, it has not been studied in the central nervous system, or in the context of
aging or age-related neurodegenerative disease. However, mitochondrial dysfunction has been shown to
correlate with increased mt-dsRNA formation, and dysfunctional mitochondria are a key hallmark of both aging
and AD that may precede neuroinflammation, especially in metabolically demanding neurons. Thus,
investigating the downstream effects of mitochondrial dysfunction in neurons due to aging and/or AD will
advance our understanding of how aging increases the risk of AD and neurodegeneration in general. The
preliminary data presented in this proposal suggest that mt-dsRNAs are released with older age and in AD,
and that they correlate with increased expression of dsRNA immune sensors. Therefore, the proposed
research is designed to test the hypothesis that age/AD-related mitochondrial dysfunction leads to
release of mt-dsRNAs that instigate an innate immune response. First (Aim 1), Dr. Doser will use both in
vitro and in vivo organismal models to determine if age/AD-related mitochondrial dysfunction contributes to mt-
dsRNA release. Then (Aim 2), she will use similar approaches to determine if mt-dsRNAs cause
neuroinflammation. Finally (Aim 3), Dr. Doser will investigate if /how mt-dsRNA levels correlate with cognitive
function or AD pathology in humans. Together, these aims will detail the hypothesized mechanism linking
age/AD-related mitochondrial dysfunction to neuroinflammation and assess its relevance to human
health/function, and they may identify novel targets for preventing or limiting inflammation. The proposed
studies will provide Dr. Doser with extensive new training in translational research using multiple models. She
will leverage and expand her current skillset, including by learning new cutting-edge techniques such as
bioinformatics, human neuronal cell culture and reprogramming, measurements of mitochondrial function and
clinical/data science. The relevant expertise of Dr. Doser’s sponsor, Dr. LaRocca, and consulting mentors Drs.
Karyn Hamilton and Chris Link, will support successful completion of the proposed aims and provide Dr. Doser
with an exceptional, interdisciplinary and translational research training experience.

Public health relevance
PROJECT NARRATIVE Mitochondrial dysfunction and neuroinflammation are major hallmarks of brain aging and age-related neurodegenerative diseases, such as Alzheimer’s disease, and although abnormal mitochondrial function appears to precede inflammation, it remains unclear if or how mitochondrial dysfunction initiates inflammation in brain aging and Alzheimer's disease. This project will explore the potential role of mitochondria-derived double-stranded RNA, which may be released due to mitochondrial dysfunction, in activating inflammatory signaling as an early driver of age/Alzheimer’s disease-related neuroinflammation. The results may provide insight into the biology of brain aging and the development of Alzheimer’s disease.